Core C: Data Management and Statistics Core

DATA MANAGEMENT AND STATISTICAL CORE - CORE C: PROJECT SUMMARY/ABSTRACT The Data Management and Statistics Core (Core C) of the Johns Hopkins Alzheimer s Disease Research Center (ADRC) has two overarching goals: (1) to provide database design, data management and data distribution for investigators associated with the ADRC, (2) to provide statistical expertise to investigators associated with the ADRC, including consultation to projects associated with the ADRC, development of novel analytic methods, and mentoring young researchers. Through the provision of efficient database design and data management, Core C assures the accuracy, accessibility, and integration of data from the ADRC, and provides data sets to the National Alzheimer s Coordinating Center (NACC) and to investigators associated with the ADRC, both within the institution and at other ADC sites. Through the provision of high level statistical consultation to investigators associated with the Center, a range of projects related to the ADRC have been facilitated, novel methods have been developed, and young investigators have been trained in longitudinal methods related to cognitive decline and dementia. In the next funding cycle the Data Management and Statistics Core will continue with these aims.

Public health relevance
DATA MANAGEMENT AND STATISTICS CORE - CORE C: PROJECT NARRATIVE The Johns Hopkins Alzheimer s Disease Research Center (JHADRC) will address many topics important to Alzheimer s disease (AD) and related disorders, with a focus on understanding the earliest phases of AD. This emphasis is important to ultimately diagnosing and treating AD as early as possible. Accomplishing it requires data that are rigorously collected, securely archived and validly analyzed: Core C assures these requirements for the JHADRC.